Bioinformatics and Biotechnology

through the Custom Array laboratory. This second laboratory also supports the import and development of new array technologies e.g., micro-RNA arrays, that are of particular relevance to the current proposal. The Custom Array laboratory has been in operation for 7 years, and has processed over 5,500 samples to date. Core B is investing continually in state-of-the-art instrumentation: recent enhancements include a new spotted array printer (Qarray2) and several new Affymetrix fluidics workstations and scanners (in total 8 fluidics workstations and 3 high-resolution scanners each with autosamplers). Together, these laboratories have produced and assisted in the analysis of over 27,000 microarray profiles, thereby contributing critically to the research of this Program and other laboratories across SJCRH. Core B also includes substantial bioinformatics and biostatistics expertise that will provide support and computational hardware to the Program. These resources that are crucial for the completion of array based experiments include eight Ph.D.-level bioinformaticists (one of which is dedicated to this P01, Dr. Chunxu Qu) and 12 other highly skilled technical staff. Drs. Pounds and Zhao, who are faculty members in Biostatistics, also bring unique and extensive expertise in microarray data analysis. The high performance computing facility associated with Core B includes a 420-cpu Linux cluster, 150 Tb storage capacity, and a wealth of bioinformatics applications including LaserGene, Affymetrix LIMS system, Spotfire DecisionSite, R, and many other applications suitable for sequence and gene expression analysis. We seek partial support for one bioinformaticist dedicated to this Program (Dr. Chunxu Qu). RELEVANCE (See instructions): To provide molecular profiling and bioinformatics support for investigation of pediatric brain tumors PROJECT/